Mechanisms Underlying the Bone Modeling Effects of Combined Anabolic/Antiresorptive Administration

One in three women and one in five men will experience an osteoporotic fracture during their lifetime. Currently
available medications reduce fracture risk but are unable to fully restore skeletal integrity. Thus, there remains
an urgent need for osteoporosis treatments that rapidly and effectively restore bone strength. Unlike most
chronic conditions, osteoporosis has historically been treated with only one drug at a time. Attempts to
combine anabolic agents with the most commonly used antiresorptive agents (bisphosphonates) did not prove
efficacious. In contrast, we recently reported that the combination of teriparatide and the receptor activator of
nuclear factor-κB ligand (RANKL) inhibitor, denosumab, increases bone density and improves bone
microarchitecture and estimated strength more than either drug alone and more than any available therapy.
We have hypothesized that the efficacy of this combination is dependent on denosumab’s capacity to fully
block teriparatide’s stimulation of bone resorption while allowing for teriparatide-induced stimulation of bone
formation (modeling-based bone formation). In this proposal, we will directly assess the ability of teriparatide to
stimulate modeling-based bone formation when bone resorption is blocked by denosumab. Furthermore, we
will define the cellular and molecular mechanisms by which this combination achieves its efficacy. To
accomplish these aims, we will perform a short-term clinical trial in which postmenopausal osteoporotic women
are randomized to receive three-months of teriparatide, denosumab or both medications. Iliac crest bone
biopsy specimens will then be sampled from all subjects after quadruple-labeling, an innovative technique that
is able to assess the effects of short-term interventions on bone resorption and formation without requiring
“paired” biopsies in a single subject. With this technique, we are also able to evaluate treatment-induced
changes in both static and dynamic indices of bone metabolism in each bone envelope separately (cancellous,
endocortical, intra-cortical, and periosteal) and thus calculate the proportion of remodeling versus modeling-
based bone formation in each skeletal compartment. Biopsy specimens will also be used for
immunohistochemical evaluation of osteoblasts, osteoclasts, marrow adipocytes and signaling pathways that
regulate osteogenesis. An additional 3.5-mm core will be obtained for RNA analyses of bone and the marrow
microenvironment. Furthermore, cells will be isolated from marrow aspirates to evaluate for osteogenic
potential (CFU-OB), lineage markers and signaling pathway activation. The successful completion of this study
will allow us to better define the mechanisms that underlie the unparalleled efficacy of the specific combination
of RANKL inhibition and PTH-receptor stimulation. This new understanding, in turn, will provide the framework
for the design of studies with the potential to fundamentally advance osteoporosis treatment.

Public health relevance
PROJECT NARRATIVE Osteoporosis is a large and growing public health concern that affects over 20 million Americans. While no single medication is able to restore skeletal health in most patients with severe disease, one specific drug combination has recently been shown to increase bone mass more than any available agent. This proposal aims to define the mechanisms that underlie the efficacy of this drug combination and thus support the optimization of combination osteoporosis therapy. Such an advance has the potential to fundamentally improve osteoporosis management. !